Enhanced COhort methods for HIV Research and Epidemiology (ENCORE) among transgender women in the United States

In the United States, transgender women (TW) are disproportionately impacted by HIV and are prioritized in the
US national strategy to end the epidemic. Multiple individual, interpersonal, and structural vulnerabilities fuel the
HIV epidemic among TW, as well as fuel syndemic conditions (co-occurring and reinforcing diseases or other
health conditions, such as HIV, substance use, and mental health disorder, that are often a consequence of
social inequity). National cohorts are critical to monitoring epidemic trends and how major events (e.g.,
epidemics, policy change, new biomedical interventions) impact HIV and other health conditions; this is
particularly important for TW who are often excluded from national surveillance efforts. The objective of this
proposal is to use a novel, hybrid “community hub”-supported digital cohort (“hub-supported digital cohort”)
model to evaluate HIV incidence, risk factors, and syndemic conditions among TW in the US (N=3,000). In this
model, on-the-ground community “hubs” will support enrollment and retention of a racially/ethnically and
culturally diverse, nationwide digital cohort. We will refine optimal digital cohort methods while examining the
impact of structural and psychosocial syndemic experiences on HIV incidence and parameterizing mathematical
models to identify targets for future multi-level combination HIV prevention interventions. The specific aims are:
1) Determine the efficiency and acceptability of using a novel, hub-supported digital cohort model to enroll and
retain a sample of racially/ethnically diverse TW for HIV research. 2) Estimate the prevalence and characterize
patterns of syndemic experiences among TW. 3) Estimate HIV incidence in TW, followed every 6 months for at
least 24 months to identify tailored approaches for combination, multi-disciplinary HIV prevention interventions.
3.1) Examine the effect of syndemic experiences and contextual structural factors on HIV incidence among TW
in the US. 3.2) Characterize the PrEP continuum among TW and associations with HIV incidence over time,
including uptake of newly emerging formulations, longitudinal patterns of HIV risk and adherence, and the role
of syndemic classes and contextual factors in the PrEP continuum PrEP uptake, adherence, and retention. 4.)
Develop dynamic models of multi-level combination HIV prevention interventions and scale-up among TW to
simulate the impact of evaluated interventions on HIV incidence through 2030, corresponding to the National
HIV strategy. There is a need to refine and evaluate hybrid digital cohort models with attention to mitigating
selection bias and attrition of vulnerable populations – an area of research particularly important for an epidemic
underscored by social and health disparities. Our explicit efforts to develop a hybrid cohort model center on
equity to support research participation across diverse populations and provide representative and generalizable
data. Study findings will provide critical epidemiologic parameters for future HIV prevention research, provide a
platform for exploration of other research questions, and inform the development of evidence-based and
acceptable HIV interventions to reduce HIV acquisition among transgender women in the US.

Public health relevance
Narrative Transgender women are highly burdened by the HIV epidemic in the United States. This proposal will use a novel, technology-infused “community hub”-supported digital cohort (“hub-supported digital cohort”) model to evaluate HIV incidence, syndemic conditions, and risk factors among transgender women in the US and territories (N=3,000). We will refine optimal digital cohort methods to mitigate selection bias, gather 24 months of longitudinal data from transgender women, examine individual and contextual predictors of HIV incidence, and utilize cohort and contextual data to parameterize mathematical models for the identification of effective HIV prevention interventions to change the trajectory of HIV and syndemic conditions among transgender women in the US.